Effects of age and lesion location on motor, behavioral and cognitive outcomes in pediatric posterior fossa tumors

PROJECT SUMMARY
Sixty percent of childhood brain tumors are located in the posterior fossa, which includes the cerebellum.
Children with developmental cerebellar damage are at an increased risk for a range of adverse outcomes,
including higher rates of autism diagnoses and long term cognitive and academic challenges. Traditionally
considered a motor structure, extensive evidence now links the cerebellum to various cognitive and behavioral
functions, and atypical cerebellar structure and function has been reported in multiple neurodevelopmental and
psychiatric disorders. A key feature of cerebellar neuroanatomy is the existence of functional subregions that
support sensorimotor and multiple non-motor functions. This leads to the hypothesis that motor, cognitive, and
behavioral outcomes should be predictable based on lesion location. While our previous lesion-symptom
mapping studies have shown this to be the case in adult cerebellar stroke patients, there are limited studies
linking location of lesion to outcomes in pediatric populations. Further, we and others have proposed that the
learning mechanisms subserved by the cerebellum are critical during development, leading to the hypothesis
that cerebellar damage at a younger age would be associated with worse long-term outcomes than damage in
adulthood. Based on findings from preterm infants with perinatal cerebellar damage, early cerebellar damage
could lead to the atypical development of specific cortical regions to which the cerebellum interconnects in a
lesion location-dependent manner. To test these hypotheses, we propose to analyze pre-existing structural
imaging and neuropsychological data from ~70 children with a history of pediatric cerebellar tumor. We will
conduct multivariate voxel-based lesion-symptom mapping to determine the relationship between lesion
location and various motor, cognitive, and behavioral outcome variables; we will specifically examine the
impact of age at tumor diagnosis and treatment protocols on these outcomes; and, in patients with longitudinal
data, we will examine the impact of age of tumor diagnosis and lesion location on long term outcomes and
whole-brain grey and white matter development. The goal of this research is to improve outcome prediction
and educational planning in pediatric cerebellar patients. A better understanding of the mechanism(s) by which
early cerebellar damage impacts lifelong motor, cognitive, and behavioral development may lead to new
interventions to enhance behavioral and neural outcomes for these children.

Public health relevance
PROJECT NARRATIVE Sixty percent of pediatric brain tumors involve the cerebellum and early cerebellar damage greatly increases the risk of various long-term challenges. We propose that cerebellar learning mechanisms are critically important in shaping developing brains, with both behavioral and neural outcomes linked to the location of the damage within the cerebellum. We will analyze the relationship(s) between cerebellar lesion location and developmental stage on behavioral and neural outcomes in pediatric brain tumor patients, with the goal of providing better prognostic and educational planning for these children.